SPECIALIZED DATA ENTRY FOR GENINFO DATABASES

The purpose of this contract is to provide the National Library of Medicine (NLM) with machine readable biological sequence and genetic data, and associated scientific descriptive and/or bibliographic data, that are transcribed from a variety of written materials provided by NLM. The Contractor shall add sequence data to the GenInfo Backbone Database on a daily basis, using on-site (NLM) equipment.